Alcohol Policies and Child Maltreatment

[unreadable] DESCRIPTION (provided by applicant): The purpose of this project is to empirically estimate the propensity for alcohol-related public policies to influence rates of child abuse and neglect. The alcohol regulations of interest include beer, wine, and liquor taxes and prices, drunken driving laws, and licenses to sell liquor. The close association of parental alcohol abuse and the maltreatment of children suggests that alcohol control policies can be used to improve the lives of abused children. The first aim of the project is to estimate the effects of alcohol control policies in reducing the number of families and the number of children with confirmed or suspected reports of child maltreatment. The second aim is to estimate the effects of alcohol control policies in reducing the number of children with confirmed or suspected reports of the following specific types of child maltreatment: a) physical abuse; b) neglect or deprivation of necessities; c) medical neglect; d) sexual abuse; and e) psychological or emotional abuse or neglect. The third aim is to investigate the effects of alcohol control policies in reducing the number of children who die as a result of abuse or neglect. The fourth aim is to explore the effects of alcohol control policies in reducing the total number of children entering foster care and the number of children who enter foster care because of an alcohol-abusing parent or because of their own alcohol abuse. The final aim is to estimate the effects of alcohol control policies in reducing the length of time spent in foster care. This project uses secondary data from two federal data collections and other sources to estimate a reduced form equation which relates alcohol prices and policies to measures of child maltreatment. Child maltreatment will be represented by state-level counts of child abuse and neglect and children entering foster care. Count models will be used as the primary estimation technique, although duration analyses will also be used to estimate the effects that stricter alcohol control policies may have in reducing the length of time children spend in foster care. All models will also control for other state level factors which may confound the relationships between alcohol control policies and child maltreatment. to public health: The public health and policy relevance of the project derive from the detrimental effects of parental alcohol abuse problems on the health and well being of children. Children of substance abusers are at a much greater risk of physical, mental and sexual abuse, and suffer more physical and mental health problems than children in the general population. This project analyzes the propensity for alcohol control policies to reduce rates of child abuse and neglect and improve the lives of children. [unreadable] [unreadable] [unreadable] [unreadable]